Characterizing the function of locus coeruleus and pericoerulear zone activity during avoidance behavior

PROJECT SUMMARY: This proposal is in direct response to NIMH’s Strategic Goal 1, which aims to define the
brain mechanisms underlying complex behaviors by using new techniques and multidisciplinary approaches to
characterize the cellular and circuit components contributing to brain organization and function. The primary goal
of this training proposal is to dissect the neurocircuitry of local projections to the locus coeruleus (LC) from
GABAergic pericoeruleus (peri-LC) neurons in hyperarousal and avoidance behaviors. The LC has been
implicated in regulating these physiological and behavioral responses, with increased norepinephrine (NE)
resulting in increased arousal levels and anxiety-like behaviors. Recent evidence from our lab suggests that peri-
LCGABA neurons directly inhibit the LC and respond heterogeneously to different aversive stimuli. However, a
direct relationship is not yet established between peri-LCGABA activity, LCNE activity, and aversive behavioral and
physiological outputs. The central hypothesis of this proposal is that an ensemble of peri-LCGABA neurons
coordinates LCNE activity during acute stress exposure in an anti-correlated manner, which induces stimulus-
dependent changes in arousal levels and drives avoidance behaviors. The first aim of this training proposal
seeks to characterize the modulation of noradrenergic LC activity by local GABAergic projections during acute
stress exposure and examine the resulting changes in arousal levels and avoidance behaviors. Aim 1A uses in
vivo 2-photon calcium imaging to observe LCNE and peri-LCGABA activity in response to acute stressors. Aim 1B
uses clustering methods to assess the relationship between LCNE and peri-LCGABA activity during each stimulus,
while Aim 1C reinforces the specific role of peri-LCGABA activity in the stress-induced modulation of LCNE activity
by using a generalized linear model to predict LCNE activity from peri-LCGABA responses to aversive stimuli. The
second aim of this training proposal seeks to determine how arousal levels and avoidance behaviors are
coordinated by changes in LCNE and peri-LCGABA activity. Aim 2A uses designer receptors exclusively activated
by designer drugs (DREADDs) in conjunction with 2-photon imaging to assess how tonic activation or inhibition
of LCNE neurons alters avoidance behaviors and phasic LCNE activity in response to aversive stimuli. Aim 2B will
modulate peri-LCGABA activity while monitoring LCNE activity using 2-photon imaging to evaluate how changes in
peri-LCGABA activity during acute stress exposure alter LCNE activity, arousal levels, and avoidance behaviors.
During my training period, I will learn to utilize cutting-edge biological and computational techniques to perform
powerful, high-resolution investigations of neural circuitry, and I will gain valuable career development skills
through a wide variety of scientific, intellectual, and mentored opportunities. This F31 proposal is specifically
tailored to my needs and will allow me to fully engage in my individual development plan and prepare me for a
successful career as an independent neuroscientist.

Public health relevance
PROJECT NARRATIVE Anxiety disorders affect approximately 4% of the global population, including greater than 25% of adults in the U.S., and are characterized in part by symptoms of elevated physiological arousal and the avoidance of triggering situations to a degree that negatively impacts a person’s quality of life. Arousal levels and avoidance behaviors are both regulated by noradrenergic activity in the locus coeruleus, but it is unclear how this heterogeneous neuronal population coordinates avoidance behaviors in response to different stimuli. The goal of this proposal is to examine how the modulation of noradrenergic locus coeruleus activity by local inhibitory networks controls arousal levels and avoidance behaviors, which will identify potential new avenues for treatment of anxiety and stress disorders.